Phosphorylation Control of Fibroproliferative ARDS

PROJECT SUMMARY
This proposal represents a five-year research career development plan aimed at better understanding the
development of pathogenic pulmonary fibrogenesis following acute lung injury. The candidate is an Assistant
Professor of Medicine at the University of Colorado in the Division of Pulmonary Sciences and Critical Care
Medicine. The outlined proposal builds on her strong background in basic science research and develops new
translational research skills under the mentorship of Drs. Gregory Downey and Ellen Burnham. The proposed
research plan, didactics, hands-on workshops, and bench-side learning will position the candidate with a unique
set of cross-disciplinary skills that will enable her transition to independence as a basic and translational
physician-scientist in the fields of lung injury and fibrosis.
The acute respiratory distress syndrome (ARDS) is a major healthcare problem in the US. Many ARDS survivors
experience impaired long-term outcomes due to the development of pathologic pulmonary fibroproliferation. This
excessive fibroproliferation, termed fibroproliferative ARDS (FP-ARDS), is characterized by early, over-
exuberant fibroproliferative responses with accumulation of myofibroblasts and deposition of extracellular matrix,
due in part to increases in TGF-β. The ability to predict patients at risk for developing FP-ARDS will assist with
prognostication, targeting interventions, and the development of specific therapies.
Protein Tyrosine Phosphatase (PTP)-α is a widely expressed receptor-type tyrosine phosphatase. Mice
genetically deficient in PTPα (Ptpra-/-) are protected in models of pulmonary fibrosis via mechanisms affecting
cellular responsiveness to TGF-β. This proposal will evaluate the role of PTPα in the pathogenesis of FP-ARDS
and test the hypothesis that inhibition of PTPα will prevent pathologic fibroproliferation in ARDS by attenuating
TGF-β signals in fibroblasts. The candidate will address three main research aims. Specific Aim 1 will focus on
whether PTPα is required for fibroproliferative responses in ARDS. Murine models of FP-ARDS, including intra-
tracheal hydrochloric acid and H1N1 influenza will be utilized to determine if genetic absence of PTPα provides
protection from the development of fibroproliferation. Cell-type specific knockout of PTPα will further assist in
characterizing the role PTPα plays in key lung parenchymal cells. The goal of Specific Aim 2 is to better
understand the cellular mechanisms by which PTPα promotes profibrotic pathways in lung fibroblasts, with a
particular focus on TGF-β receptors and Src kinase. Specific Aim 3 leverages previously and prospectively
collected human bronchoalveolar lavage (BAL) fluid to better quantify the profibrotic environment in the lungs of
ARDS patients and determine if PTPα augments these fibroproliferative responses. In vitro experiments will
characterize cellular profibrotic responses to human ARDS BAL and correlate these responses with the long-
term clinical course of ARDS patients. A long-term goal of this proposal is to translate our anticipated findings
into the development of therapies for patients with ARDS.

Public health relevance
PROJECT NARRATIVE The acute respiratory distress syndrome (ARDS) represents a major healthcare problem in the United States, accounting annually for over 74,000 deaths, 3.6 million hospital days, and $10 billion in direct healthcare costs. Many ARDS survivors experience long term consequences as a result of persistent, excessive fibroproliferation, termed fibroproliferative ARDS (FP-ARDS). Understanding the clinical relevance of FP-ARDS and its relationship to long-term outcomes may aid in the development of novel interventions for a large subset of patients with ARDS; this proposal will aim to evaluate the role of a novel tyrosine phosphatase, PTPα, in the pathogenesis of FP-ARDS.